UAB NORC Core C: Animal Models Core

PROJECT SUMMARY – ANIMAL MODELS CORE
The Animal Models Core provides expertise in the use of animal models for nutrition/obesity research;
maintains state-of-the-art instrumentation and methodologies for the determination of energy balance (food
intake, energy expenditure, activity [spontaneous/voluntary and exercise-related], and core body temperature);
provides state-of-the-art instrumentation and methodology for the determination of body composition (dual
energy X-ray absorptiometry [DXA], quantitative magnetic resonance [QMR], and micro-computed tomography
[µCT]); provides cost-efficient services to core users; promotes interactions among investigators; and provides
training in animal models and phenotyping methods. The lab animal nutrition subcore provides expertise and
consulting in lab animal nutrition and experimental diet formulation and production, allowing increased rigor
and research opportunity in questions related to obesity in rodents, zebrafish, and other animal models. By
executing these aims, we provide our investigators and the scientific community at large with the expertise and
resources to expand their research areas using innovative scientific methodologies to acquire results with the
purpose of enhancing human health.